Molecular and Cellular Dynamics in Mammalian Signal Transduction

PROJECT SUMMARY
This MIRA proposal addresses two important avenues of discovery made by our laboratory. In
Part 1, we will examine the mechanism of allosteric activation by phosphorylation of the MAP
kinase, ERK2. This project advances the protein kinase field, by showing how protein motions
underlie the catalytic activation of ERK2 and how this impacts the action of high affinity
inhibitors. In Part 2, we will examine the mechanisms controlling the assembly and function of a
rear-polarized cellular complex, named the WRAMP structure. The WRAMP structure advances
the field of cell motility, as a new mechanism that controls the persistence of directional cell
migration and the direction of cell movement. The projects are unified by their dissection of
molecular mechanisms that control dynamics in cell signaling. This occurs at a microscopic level
by the molecular motions of protein kinases and at a macroscopic level by the assembly of
cellular protein-organelle complexes.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it dissects the mechanisms of action of molecules that go awry in cancer and other human diseases. The work in this proposal will examine previously unrecognized molecular processes which are central to the regulation of human cells. Detailed knowledge of these processes will provide information that can be used to develop new therapeutics to treat cancer and other diseases.